Laser speckle flowgraphy as early indicator of microvasculopathy in radiation-induced vision loss

PROJECT SUMMARY/ABSTRACT
At least 50% of patients treated with 125I brachytherapy for uveal melanoma experience significant vision loss
within 3-5 years after therapy. Extensive vascular pathology has been reported in the normal retina
surrounding the melanoma after 2 years or more. These findings are in line with the accepted, but incompletely
tested, concept that microangiopathy causes radiation-related vision loss due to injury of the microvascular
endothelium during radiation. This leads to progressive capillary loss after a lag period of several years. If this
hypothesis is correct, preventing the development of, or treating, radiation-induced endothelial damage in
retinal microvessels will reduce capillary loss and save vision. However, this approach has been difficult to test
because early indicators of microvascular endothelial dysfunction have yet to be established.
The objectives of the proposed project are to: facilitate earlier detection, treatment and prevention of radiation-
associated vision loss. Specifically, we expect to 1. detect early endothelial dysfunction based on reduced
blood flow and response to light flicker 2. determine whether it is predictive of subsequent capillary loss and 3.
identify molecular mechanisms of radiation-induced endothelial dysfunction. We will apply laser speckle
flowgraphy (LSFG) for noninvasive, real-time imaging and measurement of ocular blood flow, in human
subjects and mice to test our central hypothesis, that post-radiation endothelial dysfunction is driven by
mitochondrial oxidative stress, and is predictive of the severity of subsequent capillary dropout and
vision loss. We will test our hypothesis in two aims: Aim 1: Establish whether early impairment of the
microvascular endothelial function will predict microvessel drop-out and vision loss in humans after 125I
brachytherapy. For this purpose, LSFG, optical coherence tomography (OCT) and OCT-angiography (OCT-A)
and tests of visual function will be performed in a prospective cohort of patients undergoing 125I brachytherapy
for choroidal melanoma. We will test whether early impairment of ocular blood flow and flicker light-induced
vasodilation by LSFG correlate with subsequent vision loss and capillary drop-out (as detected by OCT-A). Aim
2: Test whether selective inhibition of mitoROS production in endothelium prevents the early reduction of blood
flow and subsequent loss of capillaries after radiation. In this aim, genetic mouse models in which key
regulators of mitochondrial superoxide production are inhibited or overexpressed will be used to test whether
inhibition of mitochondrial ROS in the endothelium protects from early impairment of retinal blood flow,
endothelial dysfunction and subsequent capillary dropout.
The expected outcomes of the proposed studies are knowledge of biomarkers of early radiation retinopathy
and insights into the role of endothelial-cell mitochondrial dysfunction in radiation retinopathy. Our studies have
the potential to facilitate the development of first-in-class, targeted therapies for radiation-related vision loss.

Public health relevance
PROJECT NARRATIVE The proposed research aims at dissecting the mechanisms of vision loss in patients after treatment for uveal melanoma and developing mechanism-based treatments. It is relevant to public health because its ultimate goal is to reduce visual impairment and blindness. Thus, the proposed research is directly relevant to the NIH/NEI’s mission to support research that prevents and treats eye diseases.